Development of novel endolysins targeting Cutibacterium acnes to treat acne vulgaris

PROJECT SUMMARY
Acne vulgaris (acne) affects up to 50 million people in the U.S. annually and can have significant
negative consequences on psychosocial functioning including higher rates of anxiety, low self-esteem, and
depression. Cutibacterium acnes plays a central role in acne pathogenesis. Topical and oral antibiotics to
target C. acnes remain part of first-line treatments for acne, but extensive use of antibiotics poses significant
issues including exacerbation of antibiotic resistance as well as collateral damage to the healthy commensals
in the gut and skin microbiomes. Given these drawbacks, novel antimicrobial agents that can provide
alternatives to antibiotics and selectively target C. acnes without damaging beneficial bacteria are needed.
Endolysins are phage-encoded enzymes that can degrade bacterial cell walls. Exogenously added
endolysins can quickly lyse their target bacteria and because they bind very specific epitopes in target cell
walls, they can have lytic specificity down to a single bacterial species. Given these properties, endolysins hold
enormous potential as high-specificity skin microbiome modulators. However, the diversity of endolysins known
to target C. acnes is very low and these enzymes suffer from low specificity, weak activity and poor solubility.
As such, previous efforts to discover C. acnes endolysins with commercially-relevant properties have failed.
In Phase I of this program, we leveraged our proprietary metagenomics platform and a synthetic
biology-based approach to discover novel, soluble endolysins that target C. acnes and further improve them for
high activity and specificity, overcoming this long-standing discovery bottleneck. In total, we developed 13
engineered enzymes that meet our target activity profile, including CUT-001 and CUT-002. We further
developed base hydrogel formulations of CUT-001 and CUT-002 that have strong activity, good long-term
stability, and was non-toxic / non-irritating in in vitro and in vivo safety tests. In Phase II of this program, we
propose to develop a final CUT-002 hydrogel formulation, prototype a hydrocolloid patch incorporating CUT-
002, and develop an optimized CUT-002 bioreactor fermentation process. Successful completion of Phase II
activities will result in a) two alternative product formulations/formats that meet our target product profile and
can be advanced to clinical testing and b) cost-effective production of our lead enzyme at scale to support
clinical testing and commercialization.

Public health relevance
NARRATIVE Acne vulgaris (acne) affects up to 50 million people in the U.S. annually and can have substantial negative effects on psychosocial functioning including higher rates of anxiety, low self-esteem, and depression. Antibiotics remain a first-line treatment for acne but overuse can exacerbate antibiotic resistance as well as cause collateral damage to the skin and gut microbiomes. Topaz Biosciences is developing a class of high- specificity, antimicrobial enzymes that enable targeted killing of Cutibacterium acnes, the causative bacteria of acne, while preserving the components of the healthy skin microbiome, safeguarding the skin barrier, and providing an alternative to traditional antibiotics.